Geriatric Conditions and Disablement in the Older Adult Population

DESCRIPTION (provided by applicant): Geriatric conditions, although frequently unrecognized and overlooked, are important contributors to the health status of older adults. However, geriatric conditions as a group, in contrast to diseases, have not been clearly located within current models of disability development and progression. Rather, conditions appear to operate and interact at multiple points in these models. Christine Cigolle, M.D., M.P.H. proposes to investigate the place of geriatric conditions in the disablement pathway in older adults for the Mentored Clinical Scientist Research Career Development Award (K08). Dr. Cigolle is an Assistant Professors in the Departments of Family Medicine and Internal Medicine at the University of Michigan (UM) Medical School, with appointments in the Institute of Gerontology (UM) and the VA Ann Arbor Healthcare System Geriatrics Research, Education and Clinical Center (GRECC). Her previous cross-sectional research has demonstrated the prevalence and the disability association of geriatric conditions among older adults. Funded by a NIH-NCRR KL2 Mentored Clinical Scholars Award (UM), she investigated how geriatric conditions and chronic diseases group together in older adults using latent class analysis. Her research for the KL2 Award lays the foundation for the research aims and methodologies in her K08 proposal. The overall goal of the proposed research for the K08 Award is to investigate the place of geriatric conditions in the disablement pathway in the older adult population. The research will examine five geriatric conditions: dementia, falls, urinary incontinence, poor nutrition, and multisensory impairment. The research will propose a conceptual model in which geriatric conditions share common risk factors, have an accelerated trajectory of accumulation in older adults, and result in common outcomes (e.g., disability). The research will test this model, --first, by examining the incidence and longitudinal course of geriatric conditions (individually and in aggregate), beginning with adults in middle age and extending to the oldest old; and --second, by examining geriatric conditions as a predictor of disability (taking mortality into account as a competing outcome). By investigating how geriatric conditions begin, accumulate, and co-occur in older adults over time, the proposed research aims to add new knowledge about the place of geriatric conditions in the disablement pathway and thus to contribute to ongoing efforts to link the conditions theoretically. The proposed research will utilize unique longitudinal data from the Health and Retirement Study (HRS), a nationally-representative health interview survey, and data from the HRS supplemental Aging, Demographics, and Memory Study (ADAMS). It will also make use of newly available Medicare administrative data linked to the HRS and ADAMS to further specify conditions and diseases (diagnosis codes). Dr. Cigolle's career goal is to become an independent researcher in academic Family Medicine, focusing on older adult health status, especially geriatric conditions and syndromes and disability. Her future research methods will focus on implementation and analysis of large epidemiologic studies of older adults. The research and career development training in the K08 Award proposal are designed to support both (1) the acquisition of advanced methodological skills and expertise in the epidemiology of geriatric conditions and (2) training in the design and implementation of primary data collection for large epidemiologic studies of older adults. Her mentorship team for the K08 Award proposal includes: Primary Mentor Jersey Liang, Ph.D., Professor, Department of Health Management and Policy, School of Public Health; Co-Mentor Caroline S. Blaum, M.D., M.S., Professor, Division of Geriatrics, Department of Internal Medicine; and Co-Mentor Kenneth Langa, M.D., Ph.D., Professor, Division of General Internal Medicine, Department of Internal Medicine. Specific career development training activities include: --training in advanced statistical methodologies, including longitudinal analysis, latent trajectory analysis, hierarchical linear modeling, and survival analysis via tutorials with mentors and classwork through the Institute for Social Research and School of Public Health at the University of Michigan, --training in the use of Medicare administrative data via tutorials with mentors and course attendance at CMS 101: Introduction to the Use of Medicare Data for Research (Basic Workshop in Medicare Administrative Data) through the Research Data Assistance Center (ResDAC) at the University of Minnesota, and --training in primary data collection for large epidemiologic studies of older adults via participation in the NIA- funded ADAMS pilot study (National Trends in Brain Health) (Mentor: Langa), development of an experimental module on geriatric conditions to be submitted for consideration for fielding in the 2014 wave of the HRS (Mentor: Langa), and involvement in the Comparative Aging Research Program (Mentor: Liang).

Public health relevance
PUBLIC HEALTH RELEVANCE: This research investigates how older adults acquire geriatric conditions, such as falls and urinary incontinence, and how these conditions cause older adults to become disabled. Understanding the early development of geriatric conditions can lead to interventions to prevent or delay them. Project Narrative This research investigates how older adults acquire geriatric conditions, such as falls and urinary incontinence, and how these conditions cause older adults to become disabled. Understanding the early development of geriatric conditions can lead to interventions to prevent or delay them. __SpecificAimsTextDelimiter__ The overall goal of the proposed research is to investigate the place of geriatric conditions in the disablement pathway in the older adult population. The research will propose a conceptual model in which geriatric conditions share common risk factors and outcomes and have an accelerated trajectory of accumulation in older adults. The research will test this model, (1) by examining the incidence and longitudinal course of five geriatric conditions (dementia, falls, urinary incontinence, poor nutrition, and multisensory impairment) - individually and in aggregate - beginning with adults in middle age and extending to the oldest old; and (2) by examining geriatric conditions as a predictor of disability (with mortality as a competing outcome). The proposed research will analyze unique data from the Health and Retirement Study (HRS), newly available Medicare claims data linked to the HRS, and the supplemental Aging, Demographics, and Memory Study (ADAMS). The HRS is a nationally-representative prospective health interview survey of adults age 51 years and older (n=approximately 20,000) funded by the National Institute on Aging.[1,2] Its population-based sample and biennial longitudinal design make it a uniquely valuable data source to study geriatric conditions. The ADAMS is a supplement to the HRS that performed in-person clinical cognitive assessments on a sub-sample of respondents (n=856).[3] HRS and ADAMS data are supplemented with Medicare records from the Centers for Medicare and Medicaid Services for each respondent. In addition, HRS waves 2004-2010 include physical performance measures, enabling the study of the frailty in the development of geriatric conditions.[4] Although there have been multiple studies of the individual geriatric conditions and their associations with disability, there are few studies examining how multiple conditions co-occur in producing disability, and few use population-based data. Diseases and geriatric conditions are both critical components in the health status of older adults. Yet, geriatric conditions as a group, in contrast to diseases, have not been clearly located within current models of disability development and progression. Rather, conditions appear to operate and interact at multiple points in these models. By investigating how geriatric conditions begin, accumulate, and co-occur in older adults over time, the proposed research aims to add new knowledge about the place of these conditions in the disablement pathway and thus to contribute to ongoing efforts to link the conditions theoretically. The proposed research will build upon the principal investigator's (PI) (1) cross-sectional research documenting the prevalence and the disability association of geriatric conditions in the older adult population;[5] (2) National Research Service Award (NRSA) research which operationalized models of frailty in the HRS;[4] and (3) NIH-NCRR KL2 Mentored Clinical Scholars Award research investigating how geriatric conditions and chronic diseases group together in older adults, using latent class analysis. The research will test the following hypotheses: 1. Geriatric conditions have an accelerated trajectory of accumulation in older adults. 2. Geriatric conditions share common risk factors among themselves. 3. Geriatric conditions are located between aging/diseases and disability in the disablement pathway. Diseases may lead to disability by a path going through geriatric conditions and by a path independent of geriatric conditions. Geriatric conditions in turn may act outside the disease to disability path. (Figure 1) Exploratory hypotheses: 4. Older adults with different levels of cognitive impairment acquire and accumulate the other geriatric conditions in different patterns. For example, older adults with cognitive impairment not dementia (CIND), compared to older adults with normal cognition, acquire geriatric conditions early in the course of CIND. 5. Frailty is a geriatric condition, and common risk factors lead to it and the other geriatric conditions. Specific Aims: 1. Examine the incidence and longitudinal course of geriatric conditions (individually and in aggregate), beginning with middle-aged adults and extending through the oldest old. Identify risk factors for the development of geriatric conditions and for different trajectories of accumulation of geriatric conditions. (hypotheses 1 and 2) 2. Examine the incidence and longitudinal course of disability in the older adult population, and investigate the role of geriatric conditions as a predictor of disability incidence and worsening. (hypothesis 3) Exploratory Specific Aims: 3. Perform exploratory analysis of the geriatric conditions in the ADAMS subgroup (i.e., who underwent clinical assessment of cognition), investigating how geriatric conditions (other than dementia) accumulate and co-occur in older adults having different degrees of cognitive impairment. (hypothesis 4) 4. Investigate how frailty co-occurs with the other five geriatric conditions, and identify shared risk factors for frailty and the other geriatric conditions. (hypothesis 5)